CCNE1 is synthetically lethal with drug induced nuclear Cathepsin L (nCTSL)

PROJECT SUMMARY/ABSTRACT
Therapy for high-grade serous ovarian cancer (HGSOC) relies on DNA damaging agents, with a high
percentage of cancer with cyclin E amplification or overexpression having de novo or acquired
chemoresistance due in part to homologous recombination (HR) proficiency. We recently discovered that the
anti-leukemic drug clofarabine (CLF) + olaparib combination aided in the nuclear translocation of cathepsin L
(nCTSL) to induce DNA damage and sensitize OC cells to PARP inhibitors (Funding by DoDIIRA, OCRP
venue.) Although our ongoing studies substantiate the role of nCTSL in the DNA damage response (DDR), the
precise mechanism by which nCTSL induces DNA damage remains unclear. Our preliminary data has
uncovered a potential mechanism that promotes homologous repair deficiency (HRD) in CCNE1 high tumors.
CLF + ATR inhibitor (ATRi), AZD6738 induced an increase in the replication stress (RS) marker pRPA2S33 foci
validated through immunofluorescence (IF) and cell fractionated western blot analysis. This coincided with the
presence of CTSL in the nucleus. ATR knockdown (KD) or ATRi combined with CLF, synergistically decreases
OC cell survival, observed in both CCNE1 high and low expressing cell lines and in ex vivo cultures of patient
derived xenograft models in vitro. Significantly, CTSL KD confirms nCTSL's role in CLF-induced replication
stress.
This proposal aims to develop novel approaches to evaluate drug induced replication stress marker as a
means of developing novel drug combinations in high grade serous ovarian cancer in vivo and mechanistically
determine the how nCTSL attenuates CCNE levels. Continued development of novel combinations targeting
replication stress is essential, particularly in patients with PARPi resistant/recurrent tumors. The goal of this
proposal is to test our hypothesis that nCTSL mediated CCNE1 downregulation may sensitize CCNE1 driven
tumors to PARPi and ATRi treatment and restore homologous repair deficiency in vivo. The project will 1)
Demonstrate that the cytotoxicity of CLF + ATRi and CLF + PARPi saruparib is associated with nCTSL in
CCNE1 high PDX models in vivo and in syngeneic mouse model using KPCA cell line CCNE1 overexpression.
2) Determine the mechanism by which nCTSL targets CCNE1.
Continued development of novel combinations targeting replication stress is essential, particularly in patients
with PARPi resistant/recurrent tumors. Considering the challenge of resistance to first-line therapy and PARP
inhibitors, the combination of CLF with ATRi holds promise in overcoming or delaying drug resistance in
recurrent in high grade serous ovarian cancer.

Public health relevance
PROJECT NARRATIVE/LAY SUMMARY This application aims to investigate whether nuclear CTSL (nCTSL) targets CCNE1 to mediate synergy between clofarabine, ATR inhibitor AZD6738, and PARP inhibitor saruparib promoting homologous recombination deficiency and DNA damage response in high-grade serous ovarian cancer (HGSOC.)